Neural immunoregulation of post-traumatic autoimmunity

Chronic low back pain (LBP) and osteoarthritic (OA) joint pain are the most common causes of chronic
disabling pain and despite extensive investigation the pathophysiology of these conditions remains undefined
and there is considerable controversy regarding their clinical management. Clearly current hypotheses for the
progression of tissue injury to painful disability have not, short of removing the painful joint from the body,
generated effective and safe treatments. Our recent studies in the mouse tibia fracture model of complex
regional pain syndrome (CRPS) demonstrated that all CRPS patients expressed IgM autoantibodies with
pronociceptive passive transfer effects after intraplantar injection into the injured hindlimb or intrathecal
injection into muMT fracture mice lacking B cells and immunoglobulin, and these pronociceptive CRPS IgM
effects were mediated by C5a complement signaling and inflammatory cytokine release. Tibia fracture in mice
caused an increase of C5a receptor (C5aR) expressing macrophages in the fracture limb dermis and C5aR
expressing microglia in the corresponding spinal cord segments, and these activated immune cells release
pronociceptive inflammatory cytokines in response to C5a signaling. Moreover, after fracture in mice,
exaggerated neuropeptide and sympathetic adrenergic signaling stimulated pronociceptive IgM antibody
accumulation in the skin and spinal cord. These observations are potentially paradigm shifting. The central
hypothesis guiding our work is that tissue trauma causes neural activation of the innate and adaptive systems
of immunity, with localized neoantigen expression in the injured tissue and corresponding spinal cord
triggering lymph organ germinal center reactions characterized by the formation germinal B cells, with
subsequent pronociceptive immune complex deposition and complement activation supporting localized
chronic nociceptive sensitization. The primary objective of this proposal is to identify specific pharmacologic
targets for the successful treatment of LBP and OA. The specific aims are; 1) to identify the autoimmune
responses mediating nociceptive sensitization in the lumbar disc puncture (DP) mouse model of chronic LBP
and in the monosodium iodoacetate arthritis (MIA) mouse model of chronic OA knee pain, to determine the
prevalence of pronociceptive antibodies in LBP and OA patients, and to identify adaptive immune responses in
LBP patient spinal discs and OA patient joints, 2) to temporally map the formation of lymph node germinal
centers, characterized by the induction of T follicular helper cells (Tfh), germinal center B cells, and the
production of pronociceptive antibodies in the DP and MIA mouse models, and 3) to determine whether
sensory neuropeptide and sympathetic adrenergic signaling constitute a unifying mechanism for the activation
and maintenance of the immune response to tissue injury. These experiments potentially will establish a
rigorous foundation for exploring mechanisms of tissue injury induced autoimmunity, advance our
understanding of musculoskeletal pain, and identify specific targets for future clinical trials.

Public health relevance
Project Narrative The studies described in this application use translational mouse models of chronic low back pain and osteoarthritic knee pain, in conjunction with patient serum and tissue samples, to advance our understanding of the adaptive immune changes mediating the transition from tissue injury to chronic localized pain. It is anticipated that these investigations will provide foundational support for future clinical trials utilizing rituximab, avacopan, and other FDA approved treatments for autoimmune diseases. The identification of novel target specific pharmacologic treatments for these chronic musculoskeletal diseases could reduce pain and enhance the quality of life in many patients.